Dissecting the Mechanism of SETDB1 and its K867 Monoubiquitination in Lung Cancer Progression

Project Summary
Dissecting the Mechanism of SETDB1 and its K867 Monoubiquitination in Lung Cancer Progression
Non-small cell lung cancer (NSCLC) is one of the leading causes of cancer-related mortality worldwide
and associated with high mutation burdens. During the last decade, biomarker-driven targeted therapies have
achieved clear clinical benefits in patients with several oncogenic driver mutations such as EGFR, BRAF and
ALK. However, the treatments for tumors with the most prevalent KRAS mutations remain challenging despite
of recent breakthrough in targeting KRAS-G12C mutation. In KRAS mutant NSCLC, the constitutively activated
downstream signaling ultimately leads to transcription reprogramming to sustain tumor growth and progression.
This process is orchestrated by a cohort of crucial transcription factors, whose temporal and spatial expression
is associated with distinct epigenetic changes. Thus, dissecting epigenetic mechanisms in this process could
open new avenues for targeting strategies. SETDB1 is a principal methyltransferase catalyzing histone H3K9
methylation, a major repressive epigenetic modification. The focal amplification and upregulation of SETDB1
have been observed in a wide range of cancers including NSCLC, suggesting it has pro-oncogenic function.
However, the mechanisms of action of SETDB1 in NSCLC remain elusive. In preliminary study, we uncovered
that SETDB1 upregulation in lung adenocarcinoma (ADC) correlates with poorer prognosis and significantly
co-occurs with KRAS gene alternations. In NSCLC cells harboring oncogenic RAS, SETDB1 loss attenuates
migration and invasion, invadopodia formation and ECM degradation. These phenotypic changes correlate
with reactivation of transcription factors FOXA2 and CDX2 which function as key regulatory nodes to impede
metastatic progression of KRAS mutant lung ADC. More importantly, Setdb1 loss in tumor cells derived from
metastatic KrasG12D;p53fl/fl lung ADC abolished their spontaneous ability to metastasize from the subcutaneous
tumor to the lungs. These findings argue for a novel concept that SETDB1-mediated epigenetic mechanisms
are critical for oncogenic KRAS-induced transcription reprogramming during lung ADC progression. Moreover,
we have demonstrated that SETDB1 is monoubiquitinated at lysine-867 by the UBE2E family of E2 enzymes
independent of E3s and this monoubiquitination is essential for SETDB1-mediated H3K9 methylation and ERV
silencing. Accordingly, one objective of this proposal is to delineate SETDB1's pro-metastatic activity in KRAS
mutant lung ADC using various genetically engineered mouse models and xenograft models. Another objective
is to dissect the mechanisms of lysine-867 monoubiquitination in SETDB1's pro-metastatic activity in vivo and
in vitro. Our central hypothesis is that SETDB1 plays important roles in KRAS mutant lung ADC progression
through epigenetic mechanisms that require its monoubiquitination dependent enzymatic activity. This project
is significant because it will characterize SETDB1 as an actionable drug target in KRAS mutant lung cancer
and identify novel molecular interfaces for targeting. Our long-term goal is to develop better and more effective
therapeutic strategies by delineating epigenetic mechanisms in lung cancer.

Public health relevance
NARRATIVE Non-small cell lung cancer is one of the most common neoplasms worldwide and associates with poor survival and high mutation rate. Despite the significant advances in the development of molecularly targeted therapy in last decade, tumors with the most prevalent KRAS mutations remain refractory to targeted therapy. Based on compelling preliminary data, we will dissect the functional roles of SETDB1, a major H3K9 methyltransferase in regulating malignant progression of KRAS mutant non-small cell lung cancer, determine the importance of its monoubiquitination and catalytic activity, and elucidate the underlying mechanisms. This innovative project will not only decipher epigenetic mechanisms contribute to oncogenic KRAS-induced transcription reprogramming in lung cancer progression, but also highlight novel therapeutic opportunities for targeting.